Alleviating antibiotic-induced gut dysbiosis by restoring small intestinal bile acid metabolism

PROJECT SUMMARY
Antibiotic-induced damage to the natural flora of the human GI is associated with significant morbidity.
As we advance more efficient strategies to fight the current antimicrobial resistance crisis, we must also develop
therapeutic methodologies to reduce the collateral damage to the microbiome. Here we propose that the
disruption of bile acid (BA) metabolism in the upper GI by antibiotics may contribute to antibiotic-induced
dysbiosis (AID) in the lower GI and that correcting this may be a target for intervention. Host-produced BAs are
vital to the stability of the microbiome and in defining metabolites available to the host and the lower GI. The host
produces primary BAs that are deconjugated by bacteria with bile-salt hydrolase (BSH) enzymes in the small
intestine (SI). Unconjugated BAs not reabsorbed by the host are modified into secondary BAs by microbes in
the large intestine. Unconjugated and secondary bile acids can, in turn, modulate microbiome composition and
activity by inhibiting the growth of certain bacteria and by changing nutrient availability. Research on antibiotics
in the microbiome has mainly focused on fecal bacteria, leaving the impact of SI BA metabolism on AID largely
unexplored. This lack of attention to upper GI bacteria and the spatial context of host-microbe interactions
presents a significant obstacle to understanding AID. Our recent preliminary data showed that amoxicillin
severely disrupts the SI microbiota. We also found that this disruption is associated with an almost complete
reduction in the expression of BSH genes and BSH activity in the upper GI. A metabolomic analysis revealed
that amoxicillin dramatically reduced unconjugated and secondary bile acids across GI regions. This is also
associated with a reduction of lipids in the lower GI. Based on this data, we hypothesize that the depletion of
microbial bile metabolism in the SI contributes to AID by altering BA-antimicrobial activity and microbial
metabolism. The key goal of this application is to establish a causative link between the disruption of bile acid
metabolism in the upper G.I. and amoxicillin-associated damage of the lower GI microbiome. Aim 1: Determine
the role of BA metabolism in amoxicillin-induced gut dysbiosis. Aim 2: Evaluate the efficacy of BA
restoration to control antibiotic-associated pathogens. Our ultimate goal is to develop novel prebiotic,
probiotic, or pharmacological approaches to reduce the collateral impacts of antibiotics on the GI microbiota and
prevent associated health burdens. Using matched multi-omic datasets we will uncover location-specific impacts
of antibiotics over the entire length of the GI, enabling us to identify such intervention points. We envision that
dietary supplements may be a particularly effective way to restore BA metabolism, and in this application, we
test two such approaches.

Public health relevance
NARRATIVE Antibiotic-induced microbiome damage accounts for significant short-term and long-term morbidity and mortality. To effectively reduce this burden, we must develop a mechanistic understanding of how GI biogeography alters the antibiotic susceptibility of both commensal and pathogenic species. In this study, we utilize mice models to determine the relationship between antibiotics' impact on bile acid metabolism in the upper gastrointestinal tract and microbiota disruption in the lower gastrointestinal tract to achieve our long-term goal of identifying bile acid- related supplements to counteract damage to the microbiome.